Diabetes Prevention in Chinese Americans: Online Adaptation of Diabetes Prevention Program

ABSTRACT
Asians comprise a rapidly increasing proportion of immigrants in the United States with Chinese immigrants
comprising the fastest growing Asian subgroup. Despite relatively low obesity prevalence, prior research
showed that Asians had comparable, if not higher, diabetes or impaired fasting glucose prevalence compared
with other ethnic groups. Results from the Diabetes Prevention Program (DPP) have shown that an intensive
lifestyle intervention focusing on increasing physical activity and decreasing fat intake demonstrated a
significant reduction in the incidence of type 2 diabetes compared with a metformin medication group or a
control group. As a result, the DPP curriculum has been successfully translated and piloted in different
populations and settings. However, there are unique challenges inherent in adapting the DPP lifestyle
intervention for implementation in Chinese populations. For instance, low-income Chinese Americans often live
in insular communities with limited exposure to the dominant mainstream culture. Although the YMCA DPP has
widespread community-based implementation, it has not been tailored to address the cultural and linguistic
needs of Chinese-speaking Americans. In addition, similar to other immigrant groups, Chinese Americans
often work long hours with multiple jobs and do not have much free time to participate in health promotion
programs. Finding new strategies, such as delivering diabetes prevention programs online, could potentially
overcome the time barrier immigrants often face. Therefore, the aims of the SCORE SC3 project are to: 1)
adapt and translate the DPP curriculum using formative evaluation to refine strategies to promote healthy
dietary habits and increase physical activity in high-risk Chinese Americans, 2) develop an electronic version of
the adapted Chinese DPP curriculum and test its feasibility and acceptability, and 3) develop plans for
transition to non-SCORE support. The proposed project has high potential for scalability to other hard-to-reach
populations. This translation model can be easily transferred and readily adapted for use in other underserved
minority communities to prevent or reduce diabetes. In addition, with this SCORE SC3 funding support, the PI
will be able to gather needed preliminary data to generate robust applications and to transition to non-SCORE
sources of support such as NIH R01 funding mechanism.

Public health relevance
PROJECT NARRATIVE Despite relatively low obesity prevalence, Asians have a comparable, if not higher, diabetes or impaired fasting glucose prevalence compared to other ethnic groups. Although the CDC’s Diabetes Prevention Program (DPP) has wide spread community-based implementation, it has not been tailored to address the cultural and linguistic needs of Chinese-speaking Americans. The goal of this project is to adapt an online DPP curriculum that is culturally and linguistically appropriate for Chinese Americans.